Characterizing and modeling the genomewide molecular basis of gene-environment interactions

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Organismal phenotypes in a given environment frequently differ from what might be expected based on genotypic or environmental data alone. These genotype-specific deviations, or gene-environment interactions (GxE), can constitute a large portion of phenotypic variation and are important for determining an individual’s wellbeing in its given environment. An individual adapted to a particular environment can respond appropriately to typical local stresses and nutrients, but may be maladapted in new or changing environments. GxE also makes it exceedingly difficult to predict organismal response to the environment: the magnitude and direction of GxE effects depend on the loci, alleles, traits, and environments involved. This complicates extrapolation of genomic prediction models into new populations or environments. Although it is well established that GxE is a major contributor to phenotypic variation, much less is known about the molecular mechanisms determining individuals’ differential response to environments. This is particularly true in complex, real world environments that are impossible to reproduce in laboratory experiments. Genomewide, allelic variation for gene expression cumulatively influences GxE of organism-level phenotypes, but the complex networks and patterns of gene regulation driving GxE are not well understood. Over the coming five years, this project will generate new datasets and analyze existing datasets to begin understanding and modeling the genomewide patterns of gene expression that cumulatively determine GxE in real world environments. In Aim 1, tissue samples from multi-environmental experiments will be used to evaluate the landscape of gene expression among genetically variable individuals grown in a variety of environments. Specifically, we will investigate how changes to gene proximal regulatory sequences (e.g. transcription factor binding motifs) contribute to GxE for gene expression. Simultaneously, we will identify genes that show GxE for expression levels and model how they contribute to GxE for organism-level phenotypes. In Aim 2, we will use existing datasets independent yet complementary to those generated in Aim 1 to test whether GxE in organism-level phenotypes can be predicted directly from sequence variation. Together the multi-scale projects in this study range from the sequence level to the entire organism. By studying GxE at multiple scales and with a variety of different data types, this study will strengthen our understanding of how allelic sequence variation changes gene regulatory networks and drives local adaptation. These findings are important for understanding how organisms adapt to new environments and for better predicting organismal response to the environment.

Public health relevance
PROJECT NARRATIVE Gene-environment interactions (GxE) are widespread and contribute to phenotypic variation, environmental response, and adaptation, but we do not understand how genetic differences between individuals cause GxE. My research will use genome sequence, gene expression, and phenotypic data from genetically diverse individuals and a range of real-world environments to understand how GxE occurs at different scales. This research will help us to predict phenotypes across broader ranges of environmental conditions and contribute to a better understanding of how organisms adapt to new or changing environments.